Immunogen Core

PROJECT SUMMARY
Careful selection and quality production of immunogens are essential for achiving the
goals of the PlanB consortium. The Scientific Core 2 (Immunogen and Reagent Core) will
provide the necessary expertise to select and produce high quality immunogens and
immunological reagents needed for Project 1 through 4 in order to induce durably serum
neutralization and memory B cell responses.